MusiQuest STEAM: interactive digital media for K-5 STEM education integrating audio and music

Abstract Text: STEAM is an educational model that presents science,
technology, engineering, arts, and math through interdisciplinary instruction.
Research shows that STEAM programs can produce significant STEM learning
outcomes and engage a higher percentage of students than traditional STEM
instruction. However, three hurdles limit the implementation of STEAM in
elementary schools: 1) access to resources, 2) teacher expertise and bandwidth,
and 3) class management and assessment. To address these challenges, Edify
Technologies proposes to develop MusiQuest STEAM: interactive digital media
for K-5 STEM education integrating audio and music. MusiQuest STEAM
comprises innovative technical components that will be integrated into 60 total
lessons, ten each for grades K-5, which address key STEAM standards. By
incorporating audio (music, sound, hearing, etc.) in every lesson, MusiQuest
STEAM will present artistic connections to STEM that help build students'
knowledge of key concepts, and inspire their interest in learning more about
biomedical science and related research. MusiQuest STEAM will be produced by
Edify through an iterative development process in partnership with researchers at
WestEd. First, plans for MusiQuest STEAM will be reviewed by subject matters
experts. Next, two usability studies with students and teachers will help ensure
that the product's technical components and lessons are usable and effective. A
classroom feasibility study will measure MusiQuest STEAM's outputs and
outcomes in the classroom in order to determine if teachers can implement the
program with fidelity. Finally, WestEd will conduct summative research on a full
implementation of 10 Grade 3 and 4 lessons in ~30 classrooms with ~750
students. Teachers and classes will be randomly assigned to either the treatment
or control condition. The intended outcomes of this SBIR project are that: 1)
students' knowledge of grade-appropriate STEM concepts grows as measured
through formal assessments; 2) students display an understanding that audio
and music can impact human and animal health; and, 3) students demonstrate
increased interest in studying STEM and pursuing potential careers in STEM
vocations in the future– including in public health professions.

Public health relevance
Public Health Relevance Statement: MusiQuest STEAM is an interactive digital media program that combines hands-on technical components with guided lessons which address key standards for grades K-5. By incorporating audio (music, sound, hearing, etc.) in every lesson, MusiQuest STEAM will present artistic connections to STEM that help build students' knowledge of key concepts, and inspire their interest in learning more about STEM professions. The long- term impact on public health of improved outcomes in STEM education is greater participation in STEM and health-related professions.